Function, composition, and mechanism of RNA splicing factories in cardiomyopathy

PROJECT SUMMARY
Mutations in the muscle-specific splicing factor RBM20 are a recently identified cause of aggressive dilated
cardiomyopathy (DCM) characterized by severe arrhythmias. However, the underlying mechanisms are still
unclear, and thus no therapies are available. Our group recently discovered a nuclear “splicing factory” involving
RBM20 hotspots, which brings into proximity multiple co-regulated loci from different chromosomes. Formation
of this three-dimensional (3D) chromatin structure relies the nucleation of RBM20 foci by its main splicing target,
the pre-mRNA encoding for the giant protein titin (TTN). Ablating TTN transcription disrupts the RBM20 splicing
factory and dysregulates the alternative splicing of genes involved in calcium handling, including the L-type
calcium channel (CACNA1C) and calcium/calmodulin-dependent protein kinase II delta (CAMK2D). Thus, the
central hypothesis tested in this proposal is that RBM20 assembles membraneless macromolecular
condensates that control alternative splicing to centrally regulate cardiac development and disease. Our
specific aims are: (1) Identify the functional consequences of dysregulating the RBM20 splicing factory; (2)
Define the biophysical properties that drive assembly of the RBM20 splicing factory; (3) Define the key
components of the RBM20 splicing factory. In Aims 1 and 2, we will perform cellular experiments to clarify the
mechanisms and disease relevance of RBM20 focus formation, as well as functional studies using human
pluripotent stem cell-derived cardiomyocytes (hPSC-CMs). Complementing hPSC-CM monolayer cultures, we
will characterize 3D engineered heart tissues (3D-EHTs) and human myocardial grafts. We will utilize
CRISPR/Cas9 genome editing to study the effect of RBM20 DCM mutations, as well as to generate fluorescent
reporter lines to study focus dynamics in physiologically relevant models. We will characterize disease-
associated changes in 3D chromatin topology within the RBM20 splicing factory using a combination of
established sequencing- and imaging-based methods. We will then synthesize these biophysical, topological,
and biochemical changes with functional genome-wide alterations in alternative splicing, to understand the
dysregulation of cardiac electrophysiological and contractile properties. Aiming to elucidate the disease
mechanism, we will probe the pathogenic role of specific RBM20-regulated splicing isoforms for CACNA1C and
CAMK2D. In Aim 3, we will apply a novel interaction-discovery method developed in the Shechner laboratory,
oligonucleotide-directed biotinylation (ODB), to perform an unbiased “multi-omic” analysis of the composition of
the splicing factory. We will then determine the role of the newly identified splicing targets in RBM20 DCM, and
of the putative RBM20 cofactors in the regulation of RBM20 puncta architecture and of cardiac genes' alternative
splicing. Collectively, these experiments will elucidate the mechanisms by which LLPS and subnuclear
architecture collaborate to drive alternative splicing in DCM, potentially revealing novel therapeutic targets.

Public health relevance
PROJECT NARRATIVE We recently identified a novel subnuclear structure that controls alternative RNA splicing and gene co-regulation in the heart. This proposal will reveal how mutations leading to severe heart disease affect the organization and activity of this structure, and will identify new factors that are essential for its function. This work will clarify the molecular mechanisms that connect alterations in nuclear sub-compartmentalization to heart development and reveal novel molecular targets for therapeutic intervention in cardiac disease.